Small Grants Program

Project Summary for the Small Grants Program
During Phases I and II of Centers of Biomedical Research Excellence (COBRE) funding, the Pacific Center for
Emerging Infectious Diseases Research (http://pceidr.jabsom.hawaii.edu/) was transformed into a translational
science center of excellence for the development of rapid diagnostics, effective therapeutics and affordable
vaccines for infectious diseases, that disproportionately affect underserved communities in the Asia-Pacific
region. The overall objective of the Phase III COBRE is to enhance the conditions that accelerate the pace of
scientific discovery, heighten research productivity and increase competitiveness for extramural funding by
sustaining the COBRE cores and implementing a collaborative Small Grants Program. The proposed Small
Grants Program will embrace the key tenets of the IDeA Program: namely, to foster collaborative interactions;
promote data and resource sharing; identify and disseminate best practices; and develop strategies to identify
additional opportunities for core sustainability.
Thus, the COBRE Small Grants Program will harness the rich human capital and exceptional core resources at
COBRE, IDeA Networks of Biomedical Research Excellence (INBRE) and Institutional Development Award
Program Infrastructure for Clinical and Translational Research (IDeA-CTR) programs to conduct team-science
research on emerging infectious diseases. To be more responsive to the needs of faculty at different career
stages and provide additional opportunities for mentoring and specialized training, the Small Grants Program
will offer modest support on a competitive basis through three distinct funding mechanisms: (1) Pilot Projects
Program; (2) Bridging Funds Program; and (3) Faculty Exchange Program. A rigorous application and review
process, designed according to NIH guidelines, will be implemented to identify the most meritorious science
and to select the applicants with the greatest potential for long-term success. At the same time, COBRE
Mentors will also provide personalized mentoring to unfunded applicants, thereby optimizing the professional
development of local talent for careers in infectious diseases research.
Based on our experience in managing collaborative pilot projects and bridging funds program in other NIH
center grants, the expectation is that the proposed Small Grants Program will have a significant impact on
heightening research productivity and enhancing grants success. A significant return on investment, as
measured by extramural funding in the form of R-, U- and K-series grants, will serve as the scientific and
economic engines to drive future research and funding to sustain the Center and its cores.